Multimodal Analysis of the Genome Architecture Using Expansion Microscopy

SUMMARY
The three-dimensional organization of the genome regulates gene expression, impacting fundamental
biological processes in development, homeostasis and disease. Deep understanding of the relationship
between genome structure and function requires insight into 3D chromatin architecture at individual gene
loci, at high resolution and at genome-wide scale. Current approaches to visualize chromatin architecture
are limited by trade-offs between depth and breadth and cannot link 3D position with sequence information
with simultaneous profiling of transcription and epigenetic marks in single cells. Genomic methods such as
Hi-C typically analyze a population average of genomic contact information and imaging approaches such
as ChromEMT4 provide nucleosome level visualization with 1 nanometer resolution, but lack locus
identification and genome scale. Thus, there is a critical need for a broadly applicable method that
incorporates both sequence and nuclear position to reveal the spatial structure of the genome at nanometer
scale. Ideally such a method would have nucleosome resolution (~10 nm) at the single-cell level and
simultaneously provide functional readouts of epigenetic marks, transcription factors (TFs), and
transcriptional activity using multimodal labeling in the same cell. The goal of this proposal is to develop,
validate and benchmark such a method to provide genome-wide chromatin architecture analysis with
sequence information by combining iterative expansion microscopy (PanExM) with genome-wide barcoding.
This method will provide nucleosome resolution imaging of the genome with kilobase sequence resolution
while allowing multimodal protein labeling of the chromatin thanks to the protein retention during PanExM.
To achieve this: in Aim 1, we will adapt PanExM to visualize the chromatin (ChromExM), develop
multimodal labeling of DNA, RNA, TFs and epigenetic marks, develop benchmarking tools to test isotropic
expansion, structural perturbations and labeling efficiency and develop analytical and quantitative methods
to characterize how local chromatin structure regulates function. In Aim 2 we will adapt fluorescence in situ
hybridization (FISH)-based chromatin tracing to ChromExM using genome-wide barcodes as well as
specific probes to label sites of interest such as promoters and enhancers, we will develop approaches to
systematically examine enhancer-promoter interactions during transcription activation, and we will
benchmark ChromExM to established methods of super resolution microscopy, chromatin tracing and HiC.
The methods developed here will provide unprecedented resolution of the chromatin structure at the
single cell level and genome-wide, and will be broadly applicable by the research community. ChromExM
will provide much-needed tools to allow a large community of researchers to address the structural basis of
how epigenetic modifications, DNA-sequence, and chromatin proteins regulate gene expression.

Public health relevance
NARRATIVE This proposal will develop novel methods using expansion microscopy to characterize the three- dimensional structure of the genome. These methods will reveal the spatial organization of different regulatory interactions in the genome with near nucleosome resolution, with the goal of understanding how different parts of the genome interact to regulate gene expression.